Development of Self-Detoxifying Filter Media for Active Decontamination

PROJECT SUMMARY Systems that utilize various filtration media are one of the first lines of defense against aerosolized pathogens. They are critical in providing a safe/clean environment for patients, medical personnel, or researchers. Without these filters, those with compromised immune systems, or those working with highly contagious pathogens, can face deadly situations. Even with these filters in place, certain pathogens have the potential to pass through or even survive within the filter. Due to the small size of many viruses, the coronavirus SARS-CoV-2 is ~100nm, no filter is 100% effective at capturing all aerosolized pathogens. Furthermore, re- aerosolization of certain captured pathogens can also take place during normal use, when the filter is assessed to determine its remaining lifespan, or when the filter needs to be replaced entirely. Herein lies Lynntech’s focus in this area. Lynntech plans to address these shortcomings in filtration media through the addition of novel solid and stable hydroperoxy ligands that will immediately, and continually, terminate captured aerosolized pathogens such as the coronavirus SARS-CoV-2 virus that causes COVID-19. Self-detoxifying filters would allow for the complete termination of any pathogen that might normally remain active on untreated filters as well as eliminate the potential for re-aerosolization of active pathogens. This would allow for not only increased protection of those relying on the filters, but also mitigate the risks of those who would normally assess or change the filters. Many of the efforts towards the modification of filtration media for active decontamination have been partially successful, however, they have all come with their own drawbacks that Lynntech will attempt overcome with its own method of filter modification. During this Phase 1 project, Lynntech will demonstrate proof-of-concept by pursuing the following specific aims: (1) functionalization of commercial fiberglass-based filter media with hydroperoxy ligands, (2) assessment of antimicrobial properties of hydroperoxy-treated filters, and (3) evaluation of the “irreversibility” and safety of bound hydroperoxy ligands. Successful completion of these specific aims should demonstrate ample feasibility of using Lynntech’s filter modification technology and allow for Lynntech to plan more comprehensive technology development and commercialization avenues. Overall, this technology provides a great opportunity to drastically improve the safety of those who are working or healing in potentially harmful environments. This technology could even be extended to further decontamination avenues such as chemical warfare agents, or toxic industrial chemicals.

Public health relevance
PROJECT NARRATIVE Lynntech is proposing to enable active decontamination on existing filter media through surface modifications using novel safe, solid hydrogen peroxide coatings. This material retains the disinfecting capabilities of traditional hydrogen peroxide but increases upon its safety and stability when exposed to mechanical and thermal stresses. This treatment procedure is necessary and vital to combat issues related to the safety concerns caused by the aerosolization of coronavirus SARS-CoV-2.